Asymmetric Walking Protocol for Optimal Post-ACL Reconstruction Rehabilitation

Project Abstract
The primary goal of the proposed work is to provide the PI with advanced biomedical research training,
outstanding mentorship, and protected time to become a leading independent researcher in post-anterior
cruciate ligament reconstruction (ACLR) rehabilitation. A significant consequence of the approximately 250,000
anterior cruciate ligament injuries that occur annually in the United States is that unresolved neuromuscular
impairments often lead to the development of detrimental knee osteoarthritis and other debilitating
comorbidities. Despite extensive rehabilitation, protracted deficits in gait mechanics remain and directly
contribute to detrimental knee loading. Yet, a promising finding from stroke research is that an asymmetric
walking protocol can disrupt maladaptive gait mechanics and lead to the adoption of new, healthy gait patterns.
While the success of the asymmetric protocol in correcting adverse gait patterns is often assessed by the
magnitude of the between-limb gait speed perturbation, this novel intervention to our knowledge has never
been employed in post-ACLR patients. Thus, I will employ experimental gait analysis, computational modeling,
biosignal processing, and machine learning to restore healthy post-ACLR gait mechanics and reduce knee
loading as outlined by the following aims:
Aim 1. Evaluate the effectiveness of asymmetric walking protocol gait perturbation magnitudes in
restoring healthy gait in post-ACLR individuals.
Aim 2. Develop patient-specific models to evaluate the impact asymmetric walking protocol gait
perturbation magnitude has on reducing detrimental knee loading in post-ACLR individuals.
Aim 3. Generate personalized data-driven clinical algorithm to rapidly and non-invasively predict knee
loads in a clinical setting.
The results of this research will yield new therapeutic interventions and treatment guidance to improve post-
ACLR rehabilitation outcomes.
The successful execution of the proposed work will involve a strong team of interdisciplinary researchers with
skills in signal processing, machine learning, medicine, biomedical engineering, computational modelling, and
physical therapy. The PI has assembled a dynamic team with a superb reputation for mentoring others and
they will provide her with research guidance in addition to career and professional development direction and
support. This mentorship combined with strong institutional support, state-of-the-art resources, and facilities,
and dedicated protected time will allow her to successfully perform the research and training activities outlined
in her K01 Mentored Research Scientist Development Award.

Public health relevance
Project Narrative Despite extensive rehabilitation, over 250,000 anterior cruciate ligament (ACL) injuries occur each year in the United States often resulting in neuromuscular dysfunction and the development of knee osteoarthritis. However, purposeful, induced asymmetric walking has been shown to override altered neuromuscular impairment to restore healthy gait patterns. Thus, my goal is to conduct a comparative research-focused study to evaluate the effectiveness of different asymmetric walking protocols and then utilize computational modeling and machine learning to model knee loading in the clinic to determine the optimal asymmetric walking protocol to restore healthy gait in post-ACL reconstruction individuals.